Core B - Human Cell/Tissue Acquisition and Physiology Care

Project Summary
The principal goal of the Core B renewal is to provide in vitro and ex vivo human platforms to study mechanisms
regulating excitation-contraction (EC) coupling in human airway smooth muscle (HASM). The objective of Core B
is to establish, characterize and provide primary HASM cells, generate single HASM cell measurements of
cytoskeletal (CSK) stiffness and force generation (magnetic twisting cytometry – MTC), and perform human
precision cut lung slice (hPCLS) studies for all Projects and Cores. Our laboratory has over 25 years of experience
in the establishment, cultivation, and characterization of primary HASM cells. Core B will also provide asthma-
and non-asthma-derived HASM to characterize intrinsic differences engendered by disease-state and to capture
heterogeneity of human responses. hPCLS will serve as the platform to measure physiologically relevant
bronchoconstriction and dilation in intact human tissue. Additionally, we will use cytokine- and mast cell-exposure
models to mimic a T2 inflammatory milieu. Aim 1 will provide novel cellular models of HASM cell
hyperresponsiveness to explore the relationship among EC coupling, single cell shortening, and force
generation to GPCR agonists and antagonists in asthma. Using these models, Project 1 will study
mechanisms underlying TGF-β1 modulation of airway contractility; Projects 2 and 4 will elucidate mechanisms
modulating TAS2R- and OGR1-mediated HASM relaxation; and Project 3 will develop targeted therapeutics to
attenuate contractility and enhance relaxation of HASM. Aim 2 will provide an integrated tissue model of
HASM contraction and airway hyperresponsiveness (AHR) to study GPCR signaling. Using hPCLS, Project
1 will examine mechanisms by which TGF-β1 modulates constriction and dilation of small airways; Projects 2 and
4 will elucidate mechanisms by which TAS2R and ORG1 mediate dilation of small airways; and Project 3 will
discover novel ways to abrogate AHR and enhance bronchodilation with targeted therapeutics. Aim 3 will
address the mechanisms by which inflammatory mediators alter GPCR function and bronchoconstriction
in hPCLS. Using these platforms, Project 1 will address how cytokines modulate TGF-β1 effects on airway
contractility; Projects 2 and 4 will characterize the roles of TAS2R- and OGR1-mediated bronchodilation in the
context of a cytokine exposure or mast cell degranulation; and Project 3 will develop ligands that will attenuate
AHR and restore bronchodilator hyporesponsiveness despite T2 inflammation. The contribution of Core B is
significant as our models will elucidate molecular targets to abrogate AHR and enhance bronchodilation in the
context of asthma. The innovation of Core B focuses on the state-of-the-art measurements of single cell force
generation and small airway function of HASM using in vitro and ex vivo models. Further our models use only
human cells and tissue mitigating species differences that confounds the study of EC coupling in ASM. A
centralized human cell and tissue core adept in the study of HASM cells and tissue is a unique asset that will
provide quality assurance across the Program Project.

Public health relevance
Project Narrative Core B will primarily provide the quality assured and well characterized human cells, tissue and physiological measurements of airway smooth muscle shortening and contraction to all investigators in the PPG.